The impact of changes in social determinants of health on adolescent and young adult mental health during the COVID-19 pandemic: A longitudinal study of the Asenze cohort in South Africa

Social determinants of health (SDOH), such as education, employment, housing, and food security, were all
impacted by the COVID-19 pandemic and associated lockdowns. These changes to SDOH were particularly
impactful in low-and-middle-income countries (LMIC) such as South Africa in which populations have a high risk
of exposure to adversities that were exacerbated by COVID-19 lockdowns (e.g., economic instability, violence,
family separation and loss). Although several studies conducted during the pandemic linked lockdowns and
changes in SDOH to adverse mental health outcomes, these studies were predominantly cross-sectional, which
precludes the ability to evaluate: i) the impact of changes in SDOH on mental health over time; ii) whether initial
impacts of COVID-19 persist long-term; and iii) the mechanisms through which changes in SDOH impact mental
health, which are necessary for identifying potential intervention points. Further, adolescents and young adults
(AYA; ages 18-25) have not been a major focus of COVID-19 mental health research, which is a gap because
this is an age range during which individuals finish education and transition into new roles, both professional and
personal. This period is also when incident mental health disorders often first occur and shapes the probability
that they will continue. This study addresses these gaps by leveraging an existing large, population-based cohort
of over 1100 AYA and their caregivers in in South Africa, the Asenze cohort. Four waves of data collection
through 2022 have captured longitudinal measurements on mental, behavioral, and physical health outcomes
as well as SDOH correlates. This provides a rare opportunity to investigate changes in AYA mental health before,
during, and after the height of the pandemic in a LMIC that has been substantially impacted by COVID-19 –
South Africa has experienced the highest number of COVID-19 cases, deaths, and excess mortality due to the
pandemic in Africa. In this mixed methods study, we will investigate the impact of COVID-19-related SDOH
changes on mental health among AYA in the Asenze cohort. Specifically, we will model changes in mental health
outcomes from pre-COVID-19 and the acute COVID-19 phases (Asenze Wave 3, collected 2020-2021 and Wave
4, collected 2022) to the post-acute COVID phase (Wave 5, 2024-2025) and how these changes may have been
impacted by SDOH (e.g., access to education, employment, availability of health care, food security, exposure
to violence). We will examine mechanisms (mediators) underlying the relationship between SDOH and mental
health and key populations (moderators) to foster resilience. Qualitative data building on prior qualitative and
quantitative data, will provide an in-depth, complementary, and contextual understanding on AYA mental health
during and COVID-19 and perceptions on the acceptability and appropriateness of interventions that target
mechanisms and key populations identified in the quantitative data. The findings will provide near-term
information on possible intervention points through which SDOH impacts mental health in the context of COVID-
19, and long-term information to inform intervention approaches in future public health emergencies.

Public health relevance
PROJECT NARRATIVE The impact of COVID-19 on population mental health has been substantial, however, the existing literature has been limited by the use of cross-sectional designs with a predominant focus on high income countries and older adult populations. In this study, we will longitudinally evaluate the degree to which changes in social determinants of health (SDOH) during the pandemic impacted the mental health of adolescents and young adults (AYA) over time in South Africa, a country that had the largest burden of COVID-19 in Africa. This cohort study will provide a unique opportunity to identify mechanisms through which SDOH impact mental health and can lead to targeted intervention approaches among a high priority AYA population at a critical transition time in which they are assuming new professional and personal responsibilities in the midst of unprecedented social and economic challenges exacerbated by the pandemic.